Metabolic Mechanisms of Recovery in Mild TBI

Project Summary
The occurrence of concussion, or mild TBI, has been steadily increasing in incidence over the past decade.
One possible consequence of concussion - post-concussion syndrome - can persist for weeks to months and
result in life dissatisfaction for the patient and economic burden for society. With the development of new
rodent models for mild TBI, we can now study the molecular mechanisms that mediate injury and/or protection
from a single TBI. Our previous work identified significant changes in the guanine deaminase cytosolic PSD-95
interactor (cypin) after mild and moderate TBI, and in turn, discovered small molecule cypin activators that are
neuroprotective in vitro and restore neurocognition in vivo in both mild and moderate TBI models. Cellular
concentrations of methionine, a key metabolic effector that regulates neurocognition, increases shortly after
mild TBI, and our preliminary data point to cypin as a pivotal molecule for restoring methionine levels to
baseline after TBI. We are proposing that activation of purine metabolism by cypin attenuates methionine
levels via two mechanisms: 1) by altering cellular metabolism needed for methionine production and 2) by
binding to adenosylhomocysteinase like 1 (AHCYL1), acting to inhibit adenosylhomocysteinase, which
decreases the production of the methionine precursor, homocysteine. These mechanisms can be harnessed
for therapeutic application. Our proposed work determines whether the activation of cypin can be targeted after
mild TBI to promote functional recovery in mice. Broadly, our proposed experiments will identify new molecular
targets for treating TBI patients and reducing the long-term morbidity of TBI on society.

Public health relevance
Project Narrative Concussion, or mild traumatic brain injury (mTBI), is the most common neurological condition seen in both children and adults. The incidence of concussions is increasing with a growing awareness of the possible consequences of repetitive concussions on brain health. We identified a protein that protects cognition and accelerates recovery after moderate TBI. The current studies will address whether therapeutics that target this protein can be used to promote recovery after a single mild TBI, paving the way for future drug development for human use.